Sustainable One Health Research Training Capacity in Eastern Africa

PROJECT SUMMARY
According to the Global Burden of Diseases data, sub-Saharan Africa (SSA) faces the highest burden of
zoonotic food-, water- and vector-borne diseases in the world. Through our renewal D43 application, the One
Health Eastern Africa Research Training (OHEART) program, we focus on two countries: Kenya and Ethiopia,
which collectively have more than 170 million people whose lives are intertwined with animals. Livestock and
people constantly move across borders in search of pasture and better livelihoods, exacerbating zoonotic
disease transmission. Recent epidemics and pandemics that originate from animals include Highly Pathogenic
Avian Influenza (birds), Middle Eastern Respiratory Syndrome (camels), Ebola Viral Disease (fruit bats), and
COVID-19, among others. Therefore, building the health research and training workforce using the One Health
approach has become increasingly crucial. In the last two cycles, our OHEART D43 trained a total of 18 PhD,
five postdoc and 46 laboratory technologists that are making impactful contributions. In the upcoming cycle, we
propose a research-training program using an integrated One Health approach to address priority zoonotic
pathogens of public health significance in the region. We emphasize building and strengthening capacity at the
interface of humans, animals, and the environment. We made transformative changes to ensure sustainability,
which include transitioning program leadership to eastern Africa under the leadership of Kenya Medical
Research Institute (KEMRI). The program will focus on four core institutional partners from Kenya (KEMRI and
University of Nairobi) and Ethiopia (University of Gondar and Armauer Hansen Research Institute). These
institutes represent the leading national global health research and training institutes with the mandate to train
professionals in diverse areas including infectious diseases at PhD and postdoctoral levels. Our specific aims
include: 1) Strengthen One Health research capacity in eastern Africa by expanding a sustainable pool of
research leaders; 2) Foster research collaborations between Kenya and Ethiopia, and The Ohio State
University, in major zoonotic transboundary infectious diseases; and 3) Facilitate and nurture an inter-
disciplinary collaborative environment among disciplines including medicine, veterinary medicine, nursing,
public health, environmental health and data science. We propose to scale up and train future infectious
diseases researchers and leaders in targeted priority endemic and emerging zoonotic infectious diseases
using approaches that include omics, data analytics, implementation science and applied research leadership.
Building on the success of the past two cycles, we will use two research-training tracks: Track 1.A. train six
PhD level pre-doctoral PhD fellows (three per country) with two phases of mentored research in Kenya (6-mo)
and OSU (9-mo) and remainder period at home institute; Track 1.B. two postdoctoral fellows for two years
each with 3-mo visiting fellowship at OSU using a sandwich program approach and Track 2- we will train 16
laboratory technologists via a short-term certificate program in global one health using defined competencies.

Public health relevance
Program Narrative Eastern Africa bears substantial burden of zoonotic diseases. The OHEART program targets Kenya and Ethiopia, fostering collaboration with institutions such as KEMRI, University of Nairobi, University of Gondar, AHRI, and The Ohio State University. The program aims to enhance research, leadership, cross-border cooperation, and interdisciplinary training to combat infectious diseases.